Animal Models of Emerging Viral Infection

Project 1: We previously developed a NHP ICU model and implemented NHP models with implantable telemetry to continuously monitor physiology (e.g., temperature, heart rate, blood pressure, activity). We completed a bacterial dose-response study in the NHP ICU model to determine an appropriate dose of K. pneumoniae to use in subsequent therapeutic trials. This study has been published. We are now conducting a randomized clinical trial evaluating efficacy of a host-targeted therapy in the K. pneumoniae NHP ICU model. We previously completed a pilot study of high dose (1000 plaque forming units IM) Ebola virus infection in the NHP ICU model. This past year we conducted pilot studies of low dose (1 plaque forming unit IM) Ebola virus and Marburg virus infection in NHPs with implantable telemetry. The manuscript describing this work is being drafted. In the coming year we will test the efficacy of a host-targeted therapy initiated late during Ebola virus infection, consistent with when most humans present for care.